Task A73: Tuberculosis Therapeutics Testing

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.